SPOiLER: towards Safer Prescribing of Legal Opioids from the Emergency Room

PROJECT SUMMARY
The objective of this NIDA K08 career development proposal is to gain experience and training to
become an independent investigator focused on the development of evidence-based practices to prevent and
treat substance use disorders in the emergency department. Opioid use disorders, including overdose and
addiction, have become epidemic in the United States. While research has largely focused on long-term opioid
prescribing in the outpatient setting, emergency department opioid prescribing for acute painful conditions as a
portal for future adverse patient outcomes remains poorly defined.
State governments, including the Commonwealth of Massachusetts, have reacted to the opioid crisis in
part by crafting legislation to broadly limit legal opioid prescriptions. However, opioid medications remain an
important treatment option for some acute painful conditions, and evidence based guidance on appropriate
prescribing is lacking, in part because the factors that impact providers opioid prescribing behaviors and
subsequent patient associated adverse outcomes remains unknown. Understanding the underlying
factors that influence opioid prescribing behaviors and future patient outcomes, including state legislation, peer
behaviors, hospital attitudes, and local culture, is a critical step in developing integrated, evidence-based
recommendations that focus on transforming the culture surrounding safe opioid prescribing practices.
Using the theory of planned behavior as a framework, the goals of this K08 grant application are to
understand opioid prescribing behaviors and adverse patient outcomes through the following aims: First, we
will assess the influence of state legislation, specifically the 2016 Massachusetts (MA) Opioid Law, on the
formation of hospital-based regulations and providers' perceived attitudes towards opioid prescribing through
qualitative interviews with local physician leaders in MA. Second, using comprehensive claims data, we will
evaluate the impact of the 2016 MA Opioid Law on statewide opioid prescribing, using a neighboring state
without opioid legislation as a natural control. Finally, we will examine the association of an initial opioid
prescription on clinically relevant patient outcomes in order to better understand how restricting opioid
prescriptions through legislation may impact emergency department patients presenting with an acute painful
condition.
From our results, we will create evidence-based recommendations to enhance existing opioid
legislation, as well as develop and execute R01 funded comprehensive implementation trials that focus not
only on changing behaviors of individual providers, but also transforming the group culture and social norms
that influence opioid prescribing behaviors.
!

Public health relevance
PROJECT NARRATIVE / RELEVANCE Prescription opioid medications, although an important treatment option for acute painful conditions, have contributed to the opioid epidemic through nonmedical use, dependence and addiction. Despite attempts to regulate opioids, including state legislation such as the 2016 Massachusetts (MA) Opioid Law that restricts initial opioid prescriptions, there remains a lack of evidence to adequately assess the impact of such controls, in part because the factors that influence opioid prescribing behaviors and subsequent adverse patient outcomes remain poorly understood. Using the theory of planned behavior, the proposed mentored research project will evaluate how factors, including provider characteristics, cultural and social norms, and external controls like the 2016 MA Opioid Law, influence opioid prescribing behaviors and the development of patient- level opioid related adverse clinical events for emergency department patients presenting with an acute painful condition. !